CONTROL OF CELL DIVISION IN XENOPUS OOCYTES

This research is designed to elucidate the molecular basis of the control of cell cycle proliferation. Increased understanding in this area will have important ramifications for understanding early embryonic development and the process of cancer. The work is oriented to understanding the transition from G2 to M phase in the cell cycle. We have purified and characterized the central control element in eucaryotic cells that control the G2 to M transition. This control element, known as M-phase promoting factor or MPF, is a complex between a 34 kDa protein kinase and a 45 kDa substrate. The protein kinase is a homolog of the cdc 2+ gene, termed p34cdc2 and the 45 kDa component is a cyclin that becomes phosphorylated and thiophosphorylated by p34cdc2. The p34cdc2 component is inactivated by phosphorylation. We propose to purify and characterize the protein kinases that act on p34cdc2, and determine the effect of cyclin phosphorylation on its stability and ability to associated p34cdc2. The pp60c-src proto- oncogene has been identified as a substrate of MPF, and the activation and inactivation of c-src during the cell cycle will be studied in relation to its phosphorylation by MPF. The regulation of lamin kinase activity will also be studied during the cell cycle regulation by MPF. These studies will advance fundamental knowledge about the cell cycle in terms of both how MPF activity is regulated and how MPF is actually able to cause nuclear events to occur via protein phosphorylation. The network between MPF and proto-oncogenes like c-src provides a novel basis for investigating the interface between cell cycle control and cell growth control.